Role of Eosinophils in Hepatic Ischemia Reperfusion Injury

PROJECT SUMMARY
The goal of this proposal is to investigate the functional role of eosinophils in promoting tissue repair and
regeneration after hepatic ischemia and reperfusion (IR) injury. Hepatic IR injury, which occurs during
transplantation surgery, is a major factor contributing to acute liver dysfunction and long-term complications.
Timely and robust liver repair and regeneration is vital to the resolution and recovery from ischemic liver
damage. Thus, there is a critical need to identify key pro-reparative molecular and cellular mechanisms in
order to develop therapeutic strategies to improve the outcomes of liver surgery and transplantation.
Our preliminary data demonstrated that the peak of eosinophil accumulation in the liver after IR injury
coincided with the critical time point of liver repair and regeneration. Eosinophil-deficient mice exhibited
markedly delayed and impaired tissue repair after hepatic IR injury. In contrast, adoptive transfer of WT bone
marrow-derived eosinophils (bmEos) to eosinophil-deficient mice dramatically improved liver repair to a similar
rate and extent as in the WT mice. However, interleukin (IL)-4- and IL-13-deficient bmEos could not improve
liver repair. We also found reduced EGFR activation and lower levels of HB-EGF in eosinophil-deficient mice.
Together, these findings support our hypothesis that eosinophil-derived IL-4 and/or IL-13, through
inducing HB-EGF production, play an essential role in promoting tissue repair after hepatic IR injury.
We propose three Specific Aims to (1) Investigate the role of eosinophils in liver repair after IR injury, (2)
Elucidate the mechanism by which eosinophils promote liver repair after IR injury, and (3) Explore the
potential of targeting eosinophils to accelerate liver repair after IR injury.

Public health relevance
PROJECT NARRATIVE Our studies are designed to lay the groundwork for novel therapeutic approaches to improve the outcomes of liver transplantation and other clinical conditions with hepatic ischemia reperfusion (IR) injury, such as liver resection, hemorrhagic shock and trauma. We uncovered a previously unappreciated function of eosinophils in promoting liver repair after IR injury. If successfully completed, the proposed studies will elucidate the underlying molecular mechanisms and provide strong evidence supporting the therapeutic potential of eosinophils in accelerating liver recovery after transplantation.